Leveraging Machine Learning Approaches to Understand Mechanisms of Exposure Therapy in Real-World Settings

Project Summary/Abstract
Exposure therapy is the most effective treatment available for obsessive compulsive disorder (OCD), yet up to
50% of patients do not recover. Progress has stalled because we do not fully understand how or why exposure
exerts its effects. Studies that test mechanistic theories of exposure (based on habituation or inhibitory learning
models) have yielded mixed findings for both self-report and physiological mechanisms, with a near exclusive
focus on group-level effects in tightly controlled settings. While exposure likely works differently for different
people, research on which mechanisms are most important for which individuals has been absent. As a result,
clinicians are left to navigate mixed findings from different theoretical models, leading to variability in how they
conduct exposure and greater treatment failures among patients suffering with OCD. The primary objective of
this proposal is to determine which target mechanisms are most critical to engage in real-world exposure
sessions to produce treatment response. Adult participants (N = 400) with OCD receiving exposure therapy
from two sites (McLean Hospital, San Diego State University) across the continuum of care (outpatient, partial
hospital, residential) will complete baseline clinical and demographic measures as well as weekly symptom
reports. We will measure exposure mechanisms across three levels of analysis (self-report, observer-rated
behavior, physiology) during each exposure session. Mechanisms assessed will include a broad range of
variables based on both habituation and inhibitory learning models of exposure. For self-report and observer-
rated mechanisms, we will use the Exposure Feedback Form (EFF), created and piloted by the study team.
For physiological mechanisms, we will measure skin conductance response, heart rate, and heart rate
variability via a wearable device. Leveraging machine learning analyses, we will develop a predictive model of
patient outcomes (OCD symptoms) that incorporates both mechanistic data and baseline demographic and
clinical characteristics. At the group level, we will test the hypotheses that incorporation of mechanistic
variables will improve predictive performance over baseline variables alone, and that greater habituation and
inhibitory learning will predict superior clinical outcomes. At the individual level, we will test the hypotheses that
lower baseline depression and greater anxiety sensitivity will predict stronger habituation-outcome
relationships, whereas lower baseline self-efficacy and sexual minority identity will predict stronger inhibitory
learning-outcome relationships. This will be the first study to predict mechanism-outcome relationships for
exposure therapy based on individual characteristics. Consistent with NIMH’s Strategic Objective 3, this
proposal aims to identify therapeutic targets for personalized interventions by utilizing innovative machine
learning approaches with scalable methods. Future studies will translate insights gained from this project to
test implementation of personalized medicine approaches to exposure therapy, with the ultimate goal of
improving care for the many patients who do not remit following exposure for OCD.

Public health relevance
Project Narrative Exposure therapy is the most effective treatment available for obsessive compulsive disorder, yet up to 50% of patients fail to recover because we do not understand the mechanisms underlying successful response, leading to significant variability in how clinicians conduct exposure therapy. Using machine learning to analyze patient data from real-world treatment, the current study will determine which exposure mechanisms lead to favorable clinical outcomes and what makes a good exposure for whom. Results of this study have the potential to improve personalized care for the many patients who do not remit following exposure therapy for OCD.